Core--Immune Function Studies

The Immune Function Studies Core is designed to support observational studies of post-transplantation[unreadable] immune reconstitution. The Core will perform[unreadable] multi-parameter flow cytometry analyses of T-cell and B-cell differentiation, sjTREC quantitation on[unreadable] PBMC or flow sorted T-cell subsets, and measurements of serum levels of Blys-April TNF family[unreadable] immunoregulatory factors. Core personnel will also be available to aid project investigators in the[unreadable] analysis and interpretation of multiparameter flow cytometry data. The data from these analyses will be[unreadable] used to define the course and extent of post-transplantation immune reconstitution, and will be correlated[unreadable] with the results from clinical evaluations of immune responses, patient morbidity, and graft outcome.